Effectiveness of a CBT-based mHealth Intervention Targeting MOUD Retention, Adherence, and Opioid Use

Project Abstract
The opioid epidemic has become one of the most pervasive threats to health and survival in the U.S. Medications
for the treatment of opioid use disorders (MOUD) are the gold standard treatment, with robust evidence of
effectiveness in reducing opioid use, opioid overdose risk and opioid-related deaths. Nevertheless, retention and
adherence to MOUD treatment, particularly buprenorphine (BUP), are discouragingly low; as such, novel, cost-
effective, scalable intervention approaches to increase and sustain retention and adherence to BUP treatment
are urgently needed. With NIDA support (R34 DA033196), the applicant developed and evaluated, in a RCT, a
cognitive behavioral therapy-based short message system (SMS) intervention (TXT-CBT) targeting opioid use
and medication adherence among opioid users with HIV. This highly promising intervention demonstrated
efficacy in reducing opioid use and increasing biochemically-verified antiretroviral medication adherence,
findings that were replicated among HIV-infected alcohol users (R34 AA 022055). The objective of the current
research is to adapt and extend this approach to address MOUD treatment retention and adherence. To achieve
this, we propose a 2-phase study. In Phase I,: (i) TXT-CBT is adapted, with user and MOUD provider input, to
address critical barriers to retention and adherence to BUP treatment, and transported to a scalable, user-friendly
SMS platform, to form imFREE (Interactive Messaging for Freedom from Opioid Addiction); and (ii) Usability
testing of imFREE is conducted (n=16) in preparation for an effectiveness trial. In Phase II, (i) the effectiveness
of imFREE in improving BUP treatment retention and adherence and decreasing opioid use is evaluated in an
RCT comparing imFREE to an mHealth education control condition (mHealth ED) among individuals who are
initiating BUP, and (ii) we evaluate the cost-effectiveness of imFREE. This application is an excellent fit as a
response to RFA-19-006, “Behavioral Research to Improve MAT: Behavioral and Social Interventions to Improve
Adherence to Medication Assisted Treatments for Opioid Use Disorders,” which encourages “the development
of efficacious treatments for substance use disorders that are implementable and self-sustaining, as well as
optimal behavioral strategies to promote medication adherence and improve outcomes of pharmacotherapies.”
Consistent with the objectives of the RFA, imFREE builds upon the efficacious SMS-based TXT-CBT
intervention, with content addressing retention and adherence to BUP, including mitigating risk factors for
dropout. imFREE also targets decreased opioid use, with features to notify social and provider support contacts
in the face of treatment discontinuation and/or other indicators of relapse and overdose risk. By providing support
to maximize BUP treatment adherence, coupled with skills to prevent relapse, imFREE may provide a cost-
effective, easily deployable strategy for OUD treatment and prevention of overdose deaths.

Public health relevance
PROJECT NARRATIVE The proposed research is of considerable public health significance as it will provide information to facilitate implementation of strategies to bolster retention in and adherence to addiction pharmacotherapy for individuals with opioid use disorders, a disproportionately affected subgroup of substance users for whom overdose fatalities are increasing. The technology-assisted behavioral intervention we propose to study may provide a promising, cost-effective, and easily deployable strategy for the effective treatment of opioid use disorders.